PCB induced neurogenic inflammation mediates bladder dysfunction

Lower urinary tract symptoms (LUTS) affect men and women of all ages, resulting in significant healthcare
costs and reduced quality of life. Bladder inflammation is a common cause of LUTS, which results in pain,
increased urgency and frequency of urination. Existing therapies only moderate symptoms; they do not treat
their underlying basis. The development of new and more effective methods to treat or prevent LUTS is
stymied by our incomplete understanding of how urinary function is acquired and why it deteriorates. While
environmental factors are implicated in the pathogenesis of many diseases, whether they determine individual
risk for LUTS is understudied. The goal of this project is to test the novel mechanistic hypothesis that
developmental PCB exposure induces purinergic signaling via inflammatory mechanisms, resulting in
increased afferent nerve activity and bladder voiding dysfunction. PCBs are known central nervous
system neurotoxicants, but their effects on the peripheral nervous system, which is critically involved in bladder
function, are largely unknown. To test this hypothesis, I will expose mice to a mixture of PCBs in the maternal
diet throughout gestation and lactation. The PCB mix mimics the proportions of the top 12 PCB congeners
found in the serum of mothers in California who are at risk for having a child with a neurodevelopmental
disorder. Compelling preliminary evidence implicates inflammation and purinergic signaling as a mechanism by
which early life exposure to PCBs influences young adult urinary function. I propose to build upon my previous
research experience by leveraging the environment and expertise of Dr. Lein and Dr. Bjorling to fill gaps in my
training that will facilitate my successful completion of the following specific aims testing the hypotheses that:
1) In utero and lactational PCB exposure increases bladder sensory afferent nerve fiber density coincident with
increased voiding frequency in mice. 2) PCB disposition in the urine and bladder correlate with inflammation. 3)
PCBs increase ATP and sensory afferent density by acting on the DRG neuronal cell body or peripheral axons
in contact with the urothelium. 4) Purinergic receptors mediate PCB effects on sensory afferents in vitro and
voiding dysfunction in vivo. This project will yield novel mechanistic data regarding not only the effect of
developmental PCBs on voiding function, but also the role of purinergic signaling in mediating the effects of
environment exposures that confer risk for LUTS. This information is urgently needed to inform rational
strategies for minimizing LUTS risk by mitigating relevant exposures in susceptible populations and for
identifying novel therapeutic targets. Findings from these studies will also further the development of
mechanistically based screening platforms for identifying other environmental risk factors for LUTS. Equally
important, this work will fill gaps in my training, which will allow me to realize my career goal of becoming an
independent investigator.

Public health relevance
How urinary function is acquired and why it deteriorates to cause lower urinary tract symptoms (LUTS) is not known. The proposed research will investigate how environmental neurotoxicants, specifically polychlorinated biphenyls (PCBs), act on the developing bladder to alter afferent sensory innervation and bladder function. The cumulative effort will seek to identify mechanisms by which PCBs influence LUTS risk with the ultimate goal of identifying high-risk populations and developing early monitoring and/or ameliorative strategies to decrease incidence and/or severity of LUTS.